Understanding the emotional dynamics of everyday life: modeling brain state changes and their implications for mental health

PROJECT SUMMARY / ABSTRACT
Research has shown that individuals with, or at risk for developing, mood disorders have abnormalities in
temporal aspects of their emotions in everyday life. Particularly relevant for major depressive disorder (MDD) is
emotional inertia, which indicates an emotional system that is rigid and cannot flexibly respond to changing
environmental demands. Lab studies have confirmed attenuated responses to both positive and negative
stimuli in MDD, leading to the Emotion Context Insensitivity theory. Despite the relevance of affect dynamics
for MDD, few studies have assessed the neural mechanisms that underly changing emotional states in an
ecologically-valid manner. Resting-state fMRI studies have shown that time-varying patterns within and
between fronto-insular and cortical midline brain regions have implications for both affect in daily life and MDD
severity, but with an unstructured task like rest, it is difficult to assess how these patterns reflect emotional
experiences. This project addresses these limitations through 3 specific aims that use naturalistic, emotional
stimuli: (1) Determine time-varying brain patterns associated with dynamics of emotional experience in
response to films; (2) Assess the time-varying brain patterns associated with emotions dynamics in response
to a novel experimentally-designed musical stimuli; (3) Relate individual differences in time-varying brain
patterns with individual differences in a) emotional dynamics in everyday life and b) affective traits related to
depression. The hypothesis is that time-varying activation patterns in fronto-insular, subcortical, and cortical-
midline regions will reflect changing emotions induced by movies and music and that variation in these patterns
will predict variation in positive and negative emotion dynamics in daily life (over the course of weeks) and
depression severity. Such results will specify the neural mechanisms underlying the association between
emotional inertia and depression, lending neurobehavioral support for one of several emotion theories of mood
disorders. The PI’s long-term goal is to become an NIH-funded faculty member of an R1 university, with a
research program focused on modelling brain systems involved in complex, socioemotional behaviors and
leveraging results to test new tools for characterizing, assessing risk for, and treating mood disorders. The
training objectives are to (1) acquire practical knowledge needed to apply dynamic computational models to
BOLD signal in response to naturalistic stimuli; (2) learn how clinicians conceptualize and measure affective
symptoms of mood disorders; (3) further skills in experience sampling data analysis to model affect dynamics
and predict individual differences in brain patterns; (4) enhance academic/professional skills to successfully
transition to independence. Career development will take place at Columbia University, a vibrant research
environment with outstanding resources to support the proposal, including relevant courses/ seminars, state-
of-the-art MRI facilities, and expert faculty in Computational Neuroscience, Biostatistics, and Psychiatry.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Deficits in responding adaptively to both positive and negative changes in the environment are a key feature of the debilitating and burdensome nature of mood disorders like depression, yet little neuroimaging work has focused on understanding the neural systems involved in dynamic emotional experiences and linking these findings with emotion deficits outside of the lab. In the short term, this project will provide neurobiological support for one of several competing emotion theories of depression by using dynamic computational models to a) uncover time-varying patterns of brain activation that reflect emotion fluctuations and transitions induced by movies and music and b) use spatiotemporal patterns of brain activation measured in the lab to predict individual variation in affect dynamics (over the course of weeks) in daily life and depression symptoms. In the long term, this research may help clarify and validate the relevancy of Positive and Negative Valence RDoC domains of function for various mood disorders, identify neurobehavioral subtypes of mood disorders, and inform future clinical trials designed to test targeted interventions (with neurofeedback for example) for people who express these subtypes. 1